Therapeutic targeting of a novel driver of prostate cancer progression.

Advanced prostate cancers disproportionally affect veteran populations in the US. One
key feature of the advanced diseases is the development of anti-androgen receptor
therapy resistance through a mechanism of tumor lineage plasticity, which contributes to
the lethal progression of prostate cancer. However, the mechanisms underlying the
aberration are poorly understood, which severely hinders the development of effectively
therapeutic intervention of the advanced diseases. Our preliminary studies found that a
novel reprogramming of adrenergic receptor signaling occurs in progression to lethal
forms of prostate cancer, where beta-blocker drug target gene is silenced and, in
contrast, adrenergic ligand synthesis genes, and a different member of the adrenergic
receptor family and its signaling pathway genes are induced. In line with the change,
beta-blocker displayed no significant effect on the treatment-induced neuroendocrine
prostate cancer (t-NEPC) tumors. Remarkably, small molecule antagonists of the other
adrenergic receptor developed by us and others displayed high potency in growth
inhibition of several enzalutamide-resistant /t-NEPC cell and PDX tumor models. Our
further analyses showed that the aberrant signaling stimulates programs for cancer
stem-like cell (CSC), EMT and NEPC features, with alterations of local chromatin histone
marks. Moreover, our data suggest that a chemokine receptor appears to interact with
the adrenergic receptor and facilitate the signaling. Therefore, we will take genetics,
pharmacological, functional genomics and epigenomics approaches to test the
hypotheses that reprogramming of adrenergic receptor signaling drives tumor plasticity
and therapy resistance through cross-talks and that targeting the aberrant signaling axis
is efficacious and safe for treatment of therapy-resistant, lethal forms of PCa.

Public health relevance
Prostate cancer is still one of the leading causes of cancer-related death in men including veterans in the US. Compared to the general population, prostate cancer disease in veterans tends to more often progress to the lethal forms after anti-hormone and anti-hormone receptor treatments, therefore severely affecting the life and health of our veterans. Therefore, there is still an urgent need for development of more effective therapeutics. We recently discovered a receptor protein as a new therapeutic target for the lethal form called neuroendocrine prostate (NEPC) which develops from the current treatments. Here, we propose to develop a new strategy by targeting the receptor with small-molecule inhibitors. To make it more effective, we propose to combine the receptor inhibitors with drugs targeting a different receptor target. With the promising results from preclinical models, our studies will likely lay a solid foundation for near-future development of a new and highly efficacious strategy in treatment of advanced prostate cancer for our veteran patients.